Micro-capsule technology for high-throughput analyses of cell-cell interactions

Project Summary
This proposal develops a novel technology to enable analysis of millions and eventually hundreds of millions of
live cell-cell interactions in parallel. These tools will address a major unmet need, with future potential
applications including but not limited to screening functional antibodies and peptides, evaluating ligand-
receptor specificity, and determining affinities in cell adhesion.
The technology is embodied by micro-capsules: semi-permeable compartments composed of a thin shell and a
hollow core, which can be generated extremely rapidly around cells. Micro-capsules are resilient and exchange
small molecules with surrounding media. They allow long-term cell growth, as well as multiple sequential steps
of imaging, treatment, cell fixation, staining, and sorting, including steps that are difficult or impossible to carry
out today on defined cell mixtures at high-throughput.
In this proposal, we build on proof-of-concept data to now establish and benchmark two prototype methods
that will enable screening and mapping cell interactions at a scale that is 100-10,000-fold greater than is
possible with existing plate-based or microfluidic methods, at lower cost and in less time. We use receptor
agonist/antagonist screening and mapping as test cases that allow defining clear performance indicators,
including false-positive and false-negative rates of the method. The two methods entail (1) high-throughput
screening of cell-cell interactions, and (2) high-throughput mapping of cell-cell interactions. “Screening”
focuses on selecting particular desirable interactions from a large pool, while “Mapping” refers to the task of
systematically associating variation in an input variable (e.g. DNA sequence or signaling environment) with an
output (e.g. cell activity). Currently, the only methods for systematically mapping cell-cell interactions require
using micro-well plates at low throughput.
In addition, in parallel to developing the prototype platforms, we will continue to develop capsule chemistries
and microfluidic capabilities that will enable faster screening, different capsule sizes suitable for working with
bacteria (small) to organoids (large) and multiple cell types, and to enable different screening outputs. These
capabilities are not needed for the prototypes but will generalize them.
If successful, we will have developed, optimized and benchmarked the prototype systems to the point where
they are ready for earnest application to problems in high-throughput screening and systematic mapping of
cell-cell interactions. To do so, we focus on systematically problem-solving assay design, and we incorporate
benchmarks throughout. The proposed research will significantly accelerate our ability to both gain basic
quantitative insights into cell-cell interactions in health and disease, and to enable new platforms for
therapeutic discovery.

Public health relevance
Project Narrative This proposal develops `micro-capsule' technology to enable high-throughput screening and systematic mapping of cell-cell interactions, which are central to many diseases. The new tools developed here will significantly accelerate our ability to both gain quantitative insights into how cells interact with one another in health and disease, and to enable new platforms for therapeutic discovery of proteins that change cell signaling.